Fine-grained spatial information extraction for radiology reports

ABSTRACT
Automated biomedical image classification has seen enormous improvements in performance over recent years,
particularly in radiology. However, the machine learning (ML) methods that have achieved this remarkable
performance often require enormous amounts of labeled data for training. An increasingly accepted means of
acquiring this data is through the use of natural language processing (NLP) on the free-text reports associated
with an image For example, take the following brain MRI report snippet:
There is evidence of left parietal encephalomalacia consistent with known history of prior stroke. Small
focal area of hemosiderin deposition along the lateral margins of the left lateral ventricle.
Here, the associated MRI could be labeled for both Encephalomalacia and Hemosiderin. NLP methods to
automatically label images in this way have been used to create several large image classification datasets
However, as this example demonstrates, radiology reports often contain far more granular information than
prior NLP methods attempted to extract. Both findings in the above example mention their anatomical location,
which linguistically is referred to as a spatial grounding, as the location anchors the finding in a spatial reference.
Further, the encephalomalacia finding is connected to the related diagnosis of stroke, while the hemosiderin
finding provides a morphological description (small focal area). This granular information is important for image
classification, as advanced deep learning methods are capable of utilizing highly granular structured data. This
is logical, as for instance a lung tumor has a slightly different presentation than a liver tumor. If an ML algorithm
can leverage both the coarse information (the general presentation of a tumor) while also recognizing the subtle
granular differences, it can find an optimal balance between specificity and generalizability.
From an imaging perspective, this can also be seen as a middle ground between image-level labels (which are
cheap but require significant data for training—a typical dataset has thousands of images or more) and
segmentation (which is expensive to obtain, but provides better training data—a typical dataset has 40 to 200
images), as the fine-grained spatial labels correspond to natural anatomical segments.
Our fundamental hypothesis in this project is that if granular information can be extracted from radiology reports
with NLP, this will improve downstream radiological image classification when training on a sufficiently large
dataset. For radiology, the primary form of granularity is spatial (location, shape, orientation, etc.), so this will
be the focus of our efforts. We further hypothesize that these NLP techniques will be generalizable to most types
of radiology reports. For the purpose of this R21-scale project, however, we will focus on three distinct types of
reports with different challenges: chest X-rays (one of the most-studied and largest-scale image classification
types), extremity X-rays (which offer different findings than chest X-rays), and brain MRIs (which present a
different image modality and the additional complexity of three dimensions).

Public health relevance
NARRATIVE This project is interested in developing natural language processing (NLP) methods for better understanding the spatial relationships described in the free text data within radiology reports found in electronic health record (EHR) systems. We will (i) develop an ontology, (ii) manually create a dataset for training NLP methods, (iii) develop automatic NLP methods compatible the ontology and corpus, and (iv) evaluate automatic image classification methods that use the output of the NLP system as image labels.